Georgia Veterinary Scholars Summer Research Program

Project Summary/Abstract
The aim of the Georgia Veterinary Scholars Program (NIH-GVSP) at the University of Georgia College of
Veterinary Medicine (UGA-CVM) is to immerse academically talented veterinary students from across the US in
cutting edge research, inspire them toward careers in biomedical research, and foster a deeper understanding
of the myriad roles, and vital need, for veterinarians in research. Critical to this aim is the NIH-GVSP’s
commitment to broad, inclusive recruitment of students and careful pairing with strong, cross-disciplinary mentors
capable of providing a thorough exposure to the principles underlying the conduct of research and providing a
scientific environment that instills a sense of community. A specific effort is necessary to recruit biomedical
scientists with broad medical training, such as our veterinary graduates, as partners in the nation’s biomedical
research endeavors. Veterinarians are well equipped to provide a critically needed comparative organismal
biology approach to the frontiers of biomedical research, including animal cloning, transgenics, development of
medical devices, and translational medicine. Veterinarians are also ideally trained to recognize spontaneous
animal models of human disease and are critical players in public health disciplines, emerging infectious
diseases, and food safety. Nevertheless, veterinary students are often not aware of the wealth of career
opportunities in research and, in many cases, do not recognize the role of veterinarians in these exciting areas.
Clearly, for the promises of “One Health” and translational medicine to be realized in healthier people and
animals, we will need more veterinarians engaged in research. The renewal of our training grant will help us
accomplish the critical aim of showcasing the excitement and wonder of research careers to future veterinarians
to prompt them to choose research as their career. During the 12- week summer program, seven pre-doctoral
veterinary student trainees (35 total trainees for the five-year project period) are welcomed into the discipline
and camaraderie of the scientific community and challenged to think creatively. Fundamental skills are conveyed
through seminars on ethics, responsible conduct of research, scientific rigor, animal welfare, and communication
skills. Relaxed journal club discussions, team-building exercises, and site visits to local research organizations
contribute to a sense of community and excitement about future research possibilities. The central experience
is full-time hypothesis-driven research with a mentor of the student’s choosing, culminating in written and oral
presentations at the university and national levels. The PI and the 35 mentors spanning 13 departments in 6
colleges and schools within UGA support the program. The NIH-GVSP is designed to capture the imagination of
future veterinarians at a formative time to inspire them to develop into independent investigators.

Public health relevance
Public Health Statement There has developed a great need in contemporary society for veterinarians trained in the methodology of basic research but, unfortunately, veterinary students are often not aware of the career possibilities in these areas of need. The expansion of biotechnology frontiers require contributions by veterinary scientists capable of evaluating whole animal health issues while being expert, or at least conversant, with the rapidly evolving technologies. We believe our proposed training grant (third renewal) “Georgia Veterinary Scholars Summer Research Program” will make veterinary students more aware of and likely to pursue careers in research. Such veterinary research scientists will then be particularly well equipped to identify unique features of various animal models of human disease, to advance studies in translational medicine and animal health, to navigate the interface of animal and ecological health, and to be leaders in public health.